Development, feasibility, and acceptability of Aim to Play, a user-friendly digital application for teacher skills training and physical education activities for K-2 elementary students

ABSTRACT
Fundamental movement skill (FMS) is an integral component to holistic child development and school readiness.
Serious inequalities in physical activity participation and FMS development are associated with race/ethnicity, income,
and school contexts, which further exacerbate health disparities and academic vulnerability among disadvantaged
children. Children from low-income, minority, and rural backgrounds are particularly vulnerable for not meeting FMS
benchmarks, and rely more heavily on schools to obtain quality physical activity opportunities to gain FMS development
than other children. While 40 states currently mandate elementary school physical education (PE) to promote student
public health objectives and FMS development, most marginalized students do not experience adequate PE participation
because teachers (both PE certified and regular classroom teachers who teach PE) have limited or no access to easy to use
and low cost programmatic resources for conducting effective, evidence-based, and standards-based PE. To address these
needs, the Aim to Play™ K-2 digital application (“app”) program will be designed for kindergarten through 2nd grade
classroom teachers who increasingly assume responsibility for PE instruction. These teachers consistently encounter PE
instructional challenges due to (1) inadequate facilities, planning and teaching time, and equipment; (2) varied student
skill levels and experience managing student PA; and, (3) an overall lack of instructional knowledge and training in
movement and activity skills for conducting effective PE. To address these barriers, Aim to Play™ K-2 will work across
platforms and devices to provide simple, easy to use, evidence- and standards-based PE lesson activities that can be
tailored by time, instructional location (classroom, indoors/outdoors), grade, student skill level, and equipment resources,
with an embedded data tracking feature to assist with state mandated reporting needs. The app will be low-cost and
include brief teacher skill demonstration videos for each lesson, paired with adaptable lessons for kindergarten through 2nd
grade classrooms that integrate kinesthetic cross-displace learning opportunities (i.e., vocabulary, math). Teachers will
access the program via digital handheld tablet devices, online or offline, increasing accessibility for settings with poor Wi-
Fi. During this Phase I SBIR, we plan to (1) use a participatory, iterative process to design and develop a prototype (i.e.
beta) version of the Aim to Play™ K-2 app, a cross-platform, digital program application designed for kindergarten
through 2nd grade classroom teachers, providing easy access to tailored, engaging classroom- or gym-based PE activities
that meet the needs of teachers and students, and (2) evaluate the usability, satisfaction, and acceptability of the Aim to
Play™ K-2 program in schools, as well as fidelity of implementation, with 9 elementary school teachers serving diverse
classrooms of low-income, rural, and/or minority children, as well as direct observation of student participation in
activities. If our Phase I benchmarks are met, this project will support a Phase II application. In Phase II, we plan to
modify Aim to Play™ K-2 according to feedback obtained in Phase I surveys, observations, and exit interviews; create
additional program modules; and evaluate the efficacy of Aim to Play™ K-2 via a randomized control trial evaluating
teacher PE knowledge, self-efficacy, practices, and student engagement and FMS outcomes in under-resourced schools.

Public health relevance
Project Narrative While 40 states currently have laws mandating elementary school physical education (PE) for students, classroom teachers are increasingly assuming instructional responsibilities of certified PE teachers with minimal to no training or supporting instructional resources. This contributes to inadequate PE instruction to students and negatively impacts the health of our nations’ children, particularly minority, low-income, and rural youth who rely more heavily on schools for quality physical activity opportunities than other children. This project seeks to develop the Aim to Play™ K-2 digital application, a cross-platform PE program designed for Kindergarten through 2nd grade classroom teachers. This app is a response to the training/instructional needs of elementary schools for an accessible program that can be scaled to reach teachers of low-resourced schools, and underserved student populations. Results of this project will inform a subsequent Phase II project to further develop the program and test efficacy with a diverse school-based sample in a randomized control trial.